Utilizing Polygenic Risk to Understand and Improve Outcomes: A Model for Overturning Health Disparities Through Minority-Enriched Genomics Healthcare

The goal of this 1-year project is 1) to derive community level social determinants of health and built
environment metrics using geocoding data for each CHOP eMERGE participant, 2) Describe the CHOP
eMERGE population integrating social vulnerability Index (SVI) and built environment (BE Tool) assessment
variables with existing descriptors and 3) evaluate high interest, high influence stakeholders’ perceived utility of
the eMERGE GIRA for T1D, T2D, Obesity and Asthma .
According to the National Academies population descriptors is “a concept of difference or a classification
scheme that categorizes individuals into groups or “populations” based on a perceived characteristic or
dimensions of interest.” Population descriptors can be routed in many population differences including genetics
(DNA Ancestry), societal constructs (race) as well as geographic (nationality and place-based) classifications.
Using the existing geocodes derived from participant addresses, we will compute SVI and BE Tool variables
for CHOP’s eMERGE cohort, describe the population using an expanded set of population descriptors and
engage genetics providers, researchers and trainees regarding perceived utility and equity of polygenic risk
score and multi-ancestry polygenic risk score implementation in diverse populations.

Public health relevance
NARRATIVE: The use of population descriptors is important to the interpretation of clinical genomic research across populations. This project will expand population descriptors included in the CHOP eMERGE cohort to include geographic descriptors and evaluate the perceived utility of descriptors in genomic professionals and trainees.